Structure of Malaria Parasite RNA polymerase

Project Summary
Malaria, the most wide-scale protozoan-induced infection of humans, is caused by parasites from the genus
Plasmodium, with Plasmodium falciparum being responsible for the most severe form of disease in humans.
Although there are several drugs that are currently used to treat malaria, malaria parasites have rapidly
developed resistance to all currently available frontline drugs. This demonstrates that there is an urgent and
critical need to identify novel drug targets for the development of new and effective anti-malarial drugs.
Transcription of DNA into RNA, the first step of gene expression, is carried out by RNA polymerase (RNAP) in
all life forms and viruses. Due to its essential role in life maintenance and virus replication, RNAP is a proven
drug target for antibiotic and antiviral developments. The biochemical characterization of purified RNAP in vitro
along with structural studies have played essential roles to define our understanding of the structure and function
of RNAP. Purified RNAP has also facilitated large-scale drug screening and the characterization of drug
candidate lead compounds, and structural studies of RNAPs have revealed the mechanism of drug action as
well as accelerated drug design by in silico screening.
RNA synthesis in Plasmodium parasites occurs in three organelles (nucleus, mitochondrion and non-
photosynthetic apicoplast) and is carried out by five RNAPs including three nuclear RNAPs (RNAP I, RNAP II
and RNAP III), bacteriophage-type mitochondrial RNAP and bacterial-type apicoplast RNAP. The ultimate goal
of this research will be to isolate all endogenous nuclear RNAPs from P. falciparum cells and determine the 3D
structures of these enzymes by single-particle cryo-electron microscopy (cryo-EM). These high-resolution
structures will elucidate the mechanism of transcription in Plasmodium and create valuable platforms for the
design of new antimalarial drugs targeting P. falciparum RNAPs. Finally, these structures will also provide new
insight into the evolution of RNAPs during the course of parasitic adaptation in eukaryotes.
In this proposal, we seek to establish methods to investigate the structure and function of P. falciparum RNAP
II, which is responsible for mRNAs, snRNAs and regulatory RNAs transcription. Aim 1 will use CRISPR/Cas9
genome editing to generate a stable cell line of P. falciparum expressing an affinity-labeled largest subunit (Rpb1)
of RNAP II. Aim 2 will establish a purification method of RNAP II from P. falciparum nuclear extract using a
combination of chromatographic techniques that will be tracked by an in vitro transcription assay to test RNAP II
activity. In Aim 3, we will determine the atomic-resolution 3D structure of RNAP II by cryo-EM. The proposed
work will pave the way for investigating the structure and function of all three nuclear RNAPs from Plasmodium.

Public health relevance
Public Health Relevance Statement Plasmodium falciparum is a eukaryotic pathogen that is the major causative agent for malaria, a disease that afflicts ~200 million people worldwide resulting in half a million annual deaths, mostly of children and pregnant women. With the decline in efficacy of the few currently available anti-malarial drugs and the lack of an efficacious vaccine, novel anti-malarial intervention strategies are desperately needed. The proposed research aims to characterize the structure and function of the nuclear P. falciparum RNA polymerase II, a critical enzyme governing gene expression during Plasmodium parasite development as a new therapeutic target against malaria.